Roles for integrins in control of lung barrier function

PROJECT SUMMARY
Acute respiratory distress syndrome (ARDS) is a life-threatening inflammatory lung disease that has high
morbidity and mortality rates, with 40% of patients dying making it a significant public health concern. In the
healthy human lung, the fluid in the airspace is balanced by two complementary processes: sodium-driven fluid
clearance and paracellular diffusion of fluid through the junctions between epithelial cells. ARDS is due to
dysfunction in these two processes, leading to flooding of the tiny air sacs in the lungs (the alveoli). In the
impaired lung, paracellular diffusion increases due to increased leak, but the lung compensates by increasing
sodium-driven fluid clearance. This leaves the lung functional but impaired, priming it for ARDS. The damaged
lung barrier combined with a second injury such as pneumonia, sepsis, or ventilator-induced injury can cause
severe airspace flooding, pulmonary edema, that cannot be mediated by compensatory fluid clearance.
Chronic alcohol abuse exacerbates the severity and likelihood of ARDS, by disrupting a major regulator of the
fluid balance in the lungs, tight junctions. Studies have examined factors that affect tight junctions in alveolar
epithelial cells, but a lesser studied possible interactor of tight junctions are integrins. Integrins exist as obligate
α/β heterodimer pairs that can form several functionally distinct conformations. The two forms are an inactive
bent state and an active extended state that enables high affinity ligand binding. Here we will examine integrin
expression, localization, and function in primary alveolar and airway epithelial cells. The effect of specifically
targeting integrins on paracellular permeability will be measured, along with determining the molecular
mechanisms linking integrins to the regulation of tight junctions. This approach will help evaluate integrins as a
target to regulate lung fluid balance through the control of lung epithelial tight junctions.

Public health relevance
PROJECT NARRATIVE Acute respiratory distress syndrome (ARDS) is a serious lung condition with high morbidity and mortality rates, making it a significant public health concern. The human lung maintains airspace fluid by balancing leak with fluid removal, however, claudin organization due to chronic alcohol abuse disrupts this balance by increasing leak and when paired with ARDS leads to catastrophic lung flooding. This project aims to target lung cell junctions as an approach to ameliorate lung leakage.